Hypothalamic Inflammation and Energy Homeostasis

DESCRIPTION (provided by applicant): Inflammation in peripheral tissues is implicated as a key mediator of insulin resistance and other metabolic consequences of obesity. Recent studies show that a similar inflammatory process also occurs in the hypothalamus, and that this process, unlike inflammation in peripheral tissues, is a potential cause (and not just a consequence) of obesity and associated metabolic impairment. These effects of hypothalamic inflammation are mediated in part via impaired neuronal responses to the hormones insulin and leptin, key signals in the central control of both energy homeostasis and insulin sensitivity. Our novel findings that hypothalamic proinflammatory cytokine expression occurs within just 24 h of the onset of high-fat (HF) feeding, an effect that coincides with a marked increase of caloric intake, and that both parameters are gradually return to normal over the subsequent week suggest a link between neuronal inflammatory responses and the hyperphagic response to a HF diet. Coincident with these early responses, microglia (the macrophage of the brain) accumulate in the arcuate nucleus (ARC, a key hypothalamic area for sensing input from insulin and leptin) - but not other brain areas. These and other observations strongly suggest that interactions between hypothalamic neurons and microglia are determinants of weight gain during HF feeding. Further, acute reversal of hypothalamic inflammation fully reverses systemic insulin resistance induced by 3 wk of HF feeding. Here, we propose studies to determine the time course over which hypothalamic microglia and neurons respond to HF feeding, and whether the response of microglia, neurons, or both cell types is required for this inflammation. We will also identify mechanisms underlying microglial accumulation in the ARC during HF feeding, and determine whether disruption of this microglial response predisposes to obesity. Lastly, we will investigate the mechanism whereby hypothalamic inflammatory signaling induced by HF feeding causes insulin resistance. These studies will clarify how interactions between hypothalamic neurons and microglia influence weight gain and metabolic impairment induced by HF feeding, which will inform our understanding of the pathogenesis of both obesity and insulin resistance and facilitate the discovery of new approaches to the treatment and prevention of these disorders.

Public health relevance
PUBLIC HEALTH RELEVANCE: This proposal focuses on mechanisms whereby high-fat feeding causes obesity and insulin resistance, both of which are major public health problems worldwide. Growing evidence implicates inflammation in peripheral tissues as a major cause of insulin resistance and other metabolic consequences of obesity. During high-fat feeding, inflammation also occurs in the hypothalamus, a key brain area for the control of both body weight and glucose metabolism. Unlike inflammation in peripheral tissues, hypothalamic inflammation is implicated as a cause (and not just a consequence) of both obesity and insulin resistance. By clarifying the mechanisms underlying these effects of hypothalamic inflammation, our studies will advance our understanding of obesity pathogenesis and its links to metabolic dysfunction, and identify new potential targets for the treatment of these conditions. Project Narrative This proposal focuses on mechanisms whereby high-fat feeding causes obesity and insulin resistance, both of which are major public health problems worldwide. Growing evidence implicates inflammation in peripheral tissues as a major cause of insulin resistance and other metabolic consequences of obesity. During high-fat feeding, inflammation also occurs in the hypothalamus, a key brain area for the control of both body weight and glucose metabolism. Unlike inflammation in peripheral tissues, hypothalamic inflammation is implicated as a cause (and not just a consequence) of both obesity and insulin resistance. By clarifying the mechanisms underlying these effects of hypothalamic inflammation, our studies will advance our understanding of obesity pathogenesis and its links to metabolic dysfunction, and identify new potential targets for the treatment of these conditions. __SpecificAimsTextDelimiter__ Hypothalamic Inflammation and Energy Homeostasis 2. SPECIFIC AIMS Growing evidence implicates systemic inflammation in the pathogenesis of insulin resistance and other metabolic consequences of obesity. A similar inflammatory process occurs in the hypothalamus (1-5), but unlike inflammation in peripheral tissues, this response may be a cause and not just a consequence of obesity (6, 7) and related metabolic dysfunction (5). Impaired neuronal signaling by insulin and leptin, hormones that provide critical input to brain systems governing energy homeostasis and glucose metabolism, is a key mechanism hypothesized to link hypothalamic inflammation to obesity and peripheral insulin resistance (6, 7). In peripheral tissues, obesity-induced inflammation involves both cell autonomous responses to nutrient excess and recruitment and activation of macrophages and other immune cells (8-11). By comparison, little is known about the cause(s) of hypothalamic inflammation during high-fat (HF) feeding (defined here as hypothalamic activation of the intracellular IKKβ-NFκB transcriptional pathway), and the question of whether microglia (the macrophage of the brain) (12, 13) participate in this process has yet to be addressed. Clarifying these fundamental issues is central to this proposal, and our preliminary data support hypotheses that will guide this work. We have found that in rats, hypothalamic inflammation is detected at an extraordinarily early time point -- within 24h of the onset of HF feeding (Preliminary Results, SA 1). Coincident with this response is a marked increase of caloric intake, and both parameters return to baseline values over the subsequent week. We also report that microglia accumulate in the arcuate nucleus (ARC, a key hypothalamic area for sensing input from insulin and leptin) - but not other brain areas - within 3d of switching to a HF diet, and that intracerebroventricular (icv) administration of minocycline, which inhibits microglial function (14), increases weight gain during HF feeding (Preliminary Results, SA 2). These findings support two related hypotheses that are fundamental to this proposal: 1) hypothalamic inflammation induced by HF feeding originates within key neurons, causing resistance to insulin and leptin and thereby promoting both weight gain and systemic insulin resistance, and 2) microglial responses limit this neuronal inflammation and hence limit both weight gain and insulin resistance during HF feeding. By testing these hypotheses, we seek to clarify both how the hypothalamus responds to HF feeding and how this response influences energy balance and insulin sensitivity. SPECIFIC AIM 1: To determine the relative contributions made by microglia vs. neurons to hypothalamic inflammation during HF feeding. We will use recently developed hypothalamic cell sorting technology to determine 1) the time course over which hypothalamic microglia and neurons respond to HF feeding, and 2) whether the capacity of microglia, neurons, or both cell types to signal via the IKKβ-NFκB pathway is required for hypothalamic inflammation in this setting. SPECIFIC AIM 2: To identify mechanisms underlying microglial accumulation in the ARC during HF feeding and determine whether disruption of this response increases food intake and weight gain. Here, we test the hypothesis that during HF feeding, the recruitment of microglia to the ARC occurs in response to inflammation within neurons, and that this microglial response protects against weight gain, at least during the first weeks after the change in diet, by limiting neuronal inflammation. This aim investigates both the mechanisms underlying the effect of HF feeding to induce ARC-specific microglial accumulation and whether this response impacts energy homeostasis. We will use mice with neuron-specific deletion of IKKβ (currently available in the lab) to determine if neuronal inflammation is required for this microglial recruitment process. We will also determine whether microglial signaling by IKKβ plays a role, and whether excess weight gain induced by icv minocycline during HF feeding (see Preliminary Results, SA 2) is associated with the predicted increase of hypothalamic inflammation and reduction of microglial accumulation in the ARC. SPECIFIC AIM 3: To investigate the mechanisms whereby hypothalamic inflammation contributes to peripheral insulin resistance during HF feeding. Our preliminary data offer compelling evidence that after 3 wk of HF feeding, pharmacological blockade of hypothalamic inflammation acutely reverses associated peripheral insulin resistance and glucose intolerance (see preliminary data, SA 3), while having no effect in animals fed standard chow. In this aim we seek to 1) determine if the potent insulin-sensitizing effect we have observed diminishes during prolonged HF feeding, as peripheral causes insulin resistance begin to predominate; 2) if the effect involves changes of hepatic glucose production, glucose utilization, or both; 3) determine the role the hepatic vagus nerve as a mediator of this effect, and 4) test whether peripheral insulin resistance induced by HF feeding is influenced by minocycline-induced inhibition of microglial function.